The 3E Study: Economic and Educational Contributions to Emerging Adult Cardiometabolic Health

Despite being one of the fastest growing sectors of the US and having greater risk of developing
eating pathology and more weight-related distress, Latina women are understudied,
underrepresented, and underreported in the eating disorder (ED) field and factors affecting their
disproportionate risk are largely unknown. Emerging adulthood and college are key transitional
times linked to the development of EDs, and Latina emerging adult college students are
particularly vulnerable. Intersectionality posits that individuals’ various identities interact with
systemic factors (e.g., socioeconomic position with racialized and gendered identities), resulting
in compounding discriminatory experiences that negatively impact health. Latina women have
42% greater risk of eating pathology than expected when the intersection of their ethnicity and
gender are accounted for. Hypothesis-driven, longitudinal research focused on reducing eating
pathology inequities for Latina women is lacking. Further, protective factors for eating pathology
remain understudied in the ED field, particularly for multiply marginalized women whose
experiences have historically been understudied, underrepresented, and underreported, and
warrant further investigation. The overall objective of this administrative supplemental
application is to examine economic risk factors and educational protective factors, as they
intersect with aspects of identity, that are associated with risk of eating pathology in Latina
emerging adults. We propose building on the parent grant R01HL160703-01A1 (“The 3E study:
Economic and educational contributions to emerging adult cardiometabolic health”), which is
creating a longitudinal cohort of 4,000 emerging adults at public Hispanic-Serving Institutions in
California, by adding a set of supplemental aims (and new measures) that capture a wider
breadth of eating pathology and exploring key identity-based moderators relevant for Latina
emerging adults (e.g., generational status), who are understudied, underrepresented, and
underreported in the ED literature. Using survey and daily diary data, our specific aims are to: 1)
determine the contribution of Latina emerging adults’ economic stressors to eating pathology
over time and 2) determine the contribution of educational protective factors to eating pathology
over time. This research will increase understanding of factors that contribute to higher risk for
eating pathology in Latina emerging adults, which will also enhance our knowledge of primary
prevention targets for negative cardiometabolic health outcomes in this historically
understudied, underrepresented, and underreported population.

Public health relevance
Hispanic-Serving Institutions are institutions of higher education that prioritize supporting low-socioeconomic position students of color through their educational experiences; these institutions’ efforts may also promote health among diverse young adult populations. The design of this study allows us to longitudinally examine the economic and educational determinants of eating pathology among Latina emerging adults. This study will allow for a greater understanding of factors that contribute to disproportionate risk for eating pathology, which will also enhance our knowledge of primary prevention targets for negative cardiometabolic health outcomes in this historically understudied, underrepresented, and underreported population